Chronic Kidney Disease in Children (CKiD)

PROJECT SUMMARY/ABSTRACT
For the Chronic Kidney Disease in Children (CKiD) Study renewal, we will continue to follow our existing cohort,
and will recruit children between 14 and 17 years of age to enhance the power of the study to characterize the
decline of kidney function and the development of cardiovascular disease as they transition to young adulthood.
Remote data collection will be coordinated and conducted through national laboratory contractors who can
assess vitals and obtain labs in the participant’s home. Data will be obtained between CKiD study visits by
conducting data extraction through electronic health records. The Research Electronic Data Capture (REDCap)
system will be leveraged to allow automated reporting for coordination and clinical activities and improve options
for harmonization with external cohorts including CureGN and NEPTUNE. Most importantly, it will enable the
study to collect data through web-based entry by computer or mobile phone directly by participants.
Important research questions will include (a) methods to identify risk factors for decline in kidney function during
childhood through young adulthood including acceleration of glomerular filtration rate (GFR) decline during
puberty and the effect of acute kidney injury (AKI) on chronic kidney disease (CKD); (b) statistical-based machine
learning prediction methodology to characterize the joint predictive value of clinical markers and social
determinants of disease progression for individualized inference; (c) analytic strategies to describe risk factors
for cardiovascular changes and outcomes via home blood pressure monitoring and assessing cardiac and
vascular target organ damage, including characterizing changes in biomarkers like trajectories of indicators of
metabolic bone health; (d) statistical methods to validate and refine GFR equations in young adulthood for
consistent estimates during the transition from pediatric to adult care; and (e) methods to assess effects of
therapies and exposures on outcomes including constructs of social function and emotional well-being.

Public health relevance
PROJECT NARRATIVE Children with chronic kidney disease (CKD) pose unique challenges to the health care system, which must address not only the primary kidney disorder, but the many extrarenal manifestations which include social function and emotional wellbeing, risk for cardiovascular disease and metabolic bone disease and a high mortality rate in young adulthood. The CKiD study is a landmark cohort study of children with CKD, having rallied more than 50 pediatric nephrology centers across the US and Canada to recruit and study 1100 children with mild to moderate CKD. From 2023 to 2028, the Clinical Coordinating Centers will continue to coordinate study visits with the following long term goals: enhance the current cohort to collect additional data as the new and existing cohorts become young adults; define how risk factors for GFR decline, and early cardiovascular abnormalities detected during childhood ultimately impact long-term health outcomes after transition to adulthood; examine the impact of risks developed during childhood CKD on outcomes in adulthood by linking CKiD data with external sources; and assess the social functioning and emotional well-being of children with CKD to understand their impact on subsequent clinical care and life course.